The role of microglia Nek6 in myocardial infarction-induced cognitive impairment

Various studies have reported that patients with heart failure (HF) have cognitive impairment. However, the
molecular mechanisms behind this are not well understood. Mice carrying human APOE4, which is a risk factor
for dementia in patients with cardiovascular disease, exhibited cognitive impairment after they developed HF.
These mice also had heightened number of microglia compared to littermate non-HF control mice. The
hippocampus, which is crucial to learning and memory, expressed high levels of disease-associated microglial
genes such as Tspo and Tnfsf13b. Additionally, microglia in mice with HF upregulated Nek6, which
phosphorylates histones H1 and H3, resulting in gene activation. Based on these preliminary data, we
hypothesize that Nek6 upregulation in microglia in mice with heart failure exaggerates inflammation and impairs
cognitive function. We will test this hypothesis in one specific aim. We will delineate the role of inflammation in
cognitive impairment in HF (Aim 1.1). Hippocampal inflammation, distribution of leukocyte populations, microglial
activation, source of excess microglia, amyloid plaque deposition, microglial phagocytic activity, and the role of
Tspo in memory impairment in mice with HF will be evaluated. Furthermore, the contribution of Nek6 in epigenetic
alterations in hippocampal microglia and memory dysfunction in mice with HF will be discerned (Aim 1.2).

Public health relevance
Cognitive impairment in patient with cardiovascular disease, such as heart failure (HF), is a major problem. However, the molecular mechanisms of poor cognition in HF are not known. This proposed study will investigate how epigenetic and transcriptional alterations in hippocampal microglia in HF elicit dementia.